A prospective study of male factors, fertility, and pregnancy outcomes

ABSTRACT
The proposed supplement will be based on data from Pregnancy Study Online (PRESTO), an ongoing NIH-
funded prospective cohort study that enrolls women trying to conceive and follows them from preconception
through 6 months after delivery (R01HD086742). Eligible female participants are aged 21-45 years, residents of
North America, trying to conceive, and not using contraception or fertility treatment at enrollment. After
enrollment, female participants invite their male partners to complete a baseline questionnaire. During 6/2013-
7/2022, PRESTO has enrolled more than 16,750 female participants and nearly 4,000 of their male partners. All
questionnaires are completed online and data collection continued during the COVID-19 pandemic. In April 2020,
we added new questions for both partners on COVID-19 infection and stressors related to the pandemic,
including changes in lifestyle, behaviors and health care, and in January 2021, we added questions for both
partners on SARS-CoV-2 vaccination (ever vaccinated, type of vaccine, and date of each shot). In November
2021, we added questions about booster shots. We also obtained female-reported data on male SARS-CoV-2
vaccination and COVID-19 infection data in the event that the male partner did not enroll. Since the study’s
inception, participants have reported detailed baseline data about socio-demographics, lifestyle,
anthropometrics, and medical history. On each bimonthly questionnaire (administered for up to 12 months),
female participants report additional data about their pregnancy status and any changes in their exposures or
covariates. We will use the above prospectively-collected data to examine the extent to which SARS-CoV-2
vaccination and COVID-19 infection in both partners are associated with spontaneous abortion (SAB), including
early SAB (<8 weeks of gestation). We will consider various windows of possible effects of vaccination and
infection, examine the number of vaccine doses (including boosters), and identify differences by other possible
effect modifiers (e.g., age). We will control for several confounders, including COVID-19-related stressors, and
also present results separately by early and late SAB (<8 vs. ≥8 weeks of gestation). Finally, we will examine
the effects of joint exposures in both members of a couple (e.g., both partners vaccinated, female partner
vaccinated, male partner vaccinated, vs. neither partner vaccinated). Among at least 1,600 U.S. participants who
reported a study-related conception after 12/14/2020, we will estimate the hazard ratio and 95% confidence
interval using Cox proportional hazards regression models. Our interdisciplinary research team has published
extensively on vaccine-related effects and reproductive outcomes, many of which are based on PRESTO data,
and we have the expertise necessary to study these research questions. Given our ongoing prospective data
collection throughout the pandemic, our successful recruitment of a large and diverse population of couples, and
our prospective collection of pregnancy data, PRESTO is uniquely-positioned to analyze data on vaccination
and SAB and provide essential information to the scientific community and the public on vaccine safety.

Public health relevance
PROJECT NARRATIVE Miscarriage (pregnancy loss <20 weeks of gestation) affects about 20% of North American couples and is associated with profound psychological, physical, and financial costs. Clinical trials did not evaluate the influence of COVID-19 vaccination on miscarriage risk; and while published studies of COVID-19 vaccination and miscarriage have indicated no association, most studies have relied on data from population registries, hospital discharge diagnoses, or clinic visits to identify miscarriage, which substantially under-ascertain miscarriages that occur earlier in gestation (<8 weeks). The proposed supplement will evaluate SARS-CoV-2 vaccination and COVID infection among female and male partners and their associations with risk of miscarriage, particularly early miscarriage (<8 weeks), thereby providing important information to the public on vaccine safety.